Glutamine-driven "bidirectional" metabolism regulates muscle stem cell function

Abstract: Stem cell exhaustion and related metabolic dysfunction are hallmarks of aging, compromising
tissue regeneration/renewal leading to eventual loss of tissue integrity and function. Understanding metabolic
programs necessary for proper stem cell function and aspects affected by age could open up therapeutic
targets. Our initial metabolomics analysis in the muscle stem cell (MuSC) identified glutamine metabolism as
a critical pathway during activation. Glutamine has multiple metabolic fates in mammalian cells. Aside from
direct incorporation into protein, glutamine can be metabolized to generate nucleotides, other amino acids,
and ATP via its anaplerotic metabolism in the TCA cycle in a “clockwise” direction. We have generated
preliminary data using stable isotope-enabled metabolic flux analysis to demonstrate that both glutamine-
driven oxidative and reductive or “counter-clockwise” pathways are active in muscle stem cells. Moreover, our
data suggest that these pathways are impaired in the aged cell, in part due to decreased glutaminase
expression. These preliminary findings lead to several new questions: 1- Is glutamine metabolism necessary
for stem cell function?, 2- What are the relative roles of oxidative and reductive pathways of glutamine
metabolism for energy generation and cell viability? And, 3-How does age alter glutamine metabolism, and
does restoration of these pathways restore cell function? We hypothesize that satellite cell function is
dependent on glutamine metabolism via both the oxidative pathway for energy production and the reductive
pathway, via isocitrate dehydrogenases 1 and 2 (IDH1/2), for generation of NADPH to fuel the glutathione
redox pathway, ensuring redox homeostasis. Moreover, we hypothesize that impairment of these pathways
contribute to age-related muscle stem cell dysfunction, which is reversible by restoration of glutamine
metabolism. We will test these hypotheses through the following aims. Aim1 will test the hypothesis that
glutamine-driven “bidirectional” metabolism is necessary for muscle stem cell function and myogenesis. We
will use small molecule inhibitors of glutaminase and, as a specific manipulation of the reductive pathway,
IDH2, to test this hypothesis. Aim2 will test the hypothesis that glutamine metabolism is impaired in old
MuSCs, and that correction of this deficit, via viral or genetic glutaminase gain of function approaches,
restores MuSC function and regenerative capacity to aged muscle. Aim3 will test the hypothesis that
glutamine metabolism regulates MuSC resilience through maintenance of cell redox status and attenuating
oxidative stress. We will test if the glutamine-driven reductive pathway generates isocitrate/citrate to serve as
“stored” form of NADPH for the cytosolic glutathione redox mechanism. The proposed studies will fully test
the hypothesis that glutamine metabolism is critical for muscle stem cell function, and that both oxidative and
reductive TCA metabolism contribute to stem cell proliferation and survival. Moreover, given that the
pathway appears dysfunctional in aging stem cells, our studies will test it’s potential as a therapeutic target.

Public health relevance
b. Project Narrative The hallmarks of aging include stem cell exhaustion and related mitochondrial dysfunction. We have uncovered a critical role for glutamine metabolism in the muscle stem cell through both oxidative and reductive TCA pathways, which become dysfunctional with aging. Our evidence suggests restoration of the glutamine pathway(s) rejuvenates aged stem cell function and improves myogenic capacity.